Investigator Development Core

Investigator Development Core:
Abstract
The purpose of the investigator development core (IDC) is to train a diverse workforce of
individuals able to effectively tackle transdisciplinary problems in health disparities and
inequalities as collaborative teams while still serving as leaders in their own disciplines. To fulfill
this purpose, this core will provide individualized mentorship teams for trainees, provide pilot
grant funding to launch trainee’s progression toward independence, oversee development and
completion of trainee’s individual development plans and project progression to the point of
publication and submission of applications to external funding agencies. The IDC will utilize the
Big, Feasible and Fundable (BFF) seminar series in Health Disparities and the Administrative
Core’s Interdisciplinary Research Workgroups (IRWG) activities as pipelines to recruit and
identify trainees as well as essential tools to facilitate and assess trainee acquisition of essential
skills in communicating and collaborating across disparate disciplines. By being open to both
U54 center members as well as those interested in exploring collaborative opportunities, the
BFF will also serve as the home base linking and fostering community between diverse multiple
transdisciplinary teams. Our proposed program has the advantage of providing benefit not only
to individuals selected as trainees but also to the larger campus community of potential trainees
as well as for current and potential collaborators, mentors and U54 participants.